Structure and Function of Non-Coding RNA

PROJECT SUMMARY/ABSTRACT
My group develops and uses chemical and biochemical tools to investigate the structure and function of
noncoding RNAs (ncRNA) and their complexes with proteins (RNPs) and small molecules (smRNAs). In the
context of this project, we will specifically focus on two general areas: 1) engineering fragment antigen binding
(Fabs) as chaperones for RNA/RNP/smRNA crystallography, cryoelectron microscopy (cryoEM) and as enabling
tools for RNA biology, and 2) elaborating mechanisms of RNA function, especially catalytic RNAs (ribozymes).
The terrestrial transcriptome contains vast numbers of structured RNAs within both coding and noncoding
transcripts that act alone and in concert with proteins to carry out critically important roles in nearly every facet
of cellular function. Understanding how these RNAs mediate biological function in health and disease requires
knowledge of their three-dimensional architectures. We will deploy a variety of structural biology, biophysical,
biochemical, computational and chemical approaches, including kinetic isotope effect analysis and the use of
nucleotides from an artificially expanded genetic system. The data that emerge from our recombinant Fab work
will engender a robust platform to generate Fabs that bind structured RNA with high affinity and specificity,
establish Fabs as powerful reagents in structural and mechanistic RNA biology and yield new macromolecular
structures, which have profound impact on our understanding of the underlying biology and serve as a framework
to develop and test functional hypotheses. In addition, our in-depth work on catalytic RNA will define for the first
time the relationship between catalytic structure and transition state structure, a missing link that has plagued
efforts to engineer macromoleclules with novel catalytic functions. Beyond the conceptual advances that emerge,
this work promises to deliver to the RNA community powerful Fab reagents for RNA/RNP structural and
functional studies, nucleotide analogs to support novel approaches to define RNA catalytic mechanisms, and
strategies to render large RNAs more tractable by increasing the density of information.

Public health relevance
PROJECT NARRATIVE Our understanding of human health and disease and our capacity to develop disease treatment hinges critically on knowledge of the three-dimensional architectures and functional mechanisms of cellular macromolecules and macromolecular complexes. The terrestrial transcriptome, shaped in part by the action of ribozymes, comprises RNAs and RNA-protein complexes (RNPs) that play major roles in human health and disease. Nevertheless, knowledge of RNA and RNP function and our ability to target them with small molecules remains limited due to challenges in determining their structures and mechanisms at atomic resolution. The Piccirilli laboratory proposes two lines of investigation into noncoding RNA structure and function (1) the development of target- specific synthetic antibodies as crystallization/cryoEM chaperones for obtaining structures of RNAs, RNPs, and their complexes with small molecules, and (2) use of established ribozymes as model systems and new human ribozymes as exploratory targets to develop and apply chemical approaches to achieve deep understanding of how these catalysts shape the terrestrial transcriptome in health and disease.